System Genetics of Male Infertility in the Collaborative Cross

DESCRIPTION (provided by applicant): The paradox of the genetics underlying infertility is that infertile individuals must have descended from fertile parents. Nonetheless, previous studies have attributed infertility in part to inherited genetic factors. As is the case with many pervasive human health conditions, this results from combinatorial effects of multiple genes, environmental factors and their interactions. Such small effects and interactions are often difficult to detect in both human populations and mouse models. The proposed research will identify genetic variation underlying male infertility using a new mouse population called the Collaborative Cross (CC). The CC is designed to facilitate mapping genes associated with complex traits. During the breeding process, up to 50% of incipient lines stop producing offspring and are declared extinct, and male infertility is a major mechanism of this extinction. This large and diverse population of infertile male mice can be used to better understand the biology and genetics of male infertility and its associated reproductive parameters such as sperm count and testis structure. This project is also valuable to develop new methods that apply to the CC population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Up to 10-15% of human couples are infertile and there have been many reports in recent decades of a significant decrease in male reproductive fitness (e.g. low sperm count). Research in the mouse indicates that fertility is a complex trait influenced by multiple genetic and environmental factors. The proposed research can help identify interactions between genes that affect male fertility.